Local immune modulation for beta cell replacement therapy in type 1 diabetes

PROJECT SUMMARY / ABSTRACT
The objective of this project is to induce localized immune tolerance to transplanted human beta
cells derived from renewable stem cell sources as a treatment for type 1 diabetes. We will test
our approach to prevent immune rejection of grafted human stem cell derived beta cells in diabetic
mice with elements of human immune systems. In addition, we seek to explain the detailed
biological mechanisms by which the therapy works by conducting in vitro studies using islet-
reactive human T cells. Recent advances in the generation of stem cell derived beta-like cells
(sBCs) have raised the possibility of providing a renewable source of functional beta cells for
transplantation, effectively overcoming the severe shortage of human donor islets. We have
generated simplified culture conditions that accurately and efficiently generate unlimited
quantities of glucose-responsive insulin-expressing beta cells in vitro. The stem cell derived beta
cells generated have already been used successfully for beta cell replacement therapy in animal
models. By combining cell engineering with biomaterials engineering to display negative
regulators of immunity (e.g. programmed death-ligand 1, PD-L1; and tumor necrosis factor (TNF)-
related apoptosis-inducing ligand, TRAIL), we will functionalize stem cell derived beta cells (sBCs)
to counter autoimmunity upon transplantation. A major strength of our approach is that the
immunotherapy is strongly localized to grafted beta cells, which increases specificity and avoids
the negative side effects of systemic immunotherapy. We hypothesize that stem cell derived
human pseudo islets transplanted with PD-L1 and/or TRAIL will be resistant to autoimmune
destruction and exhibit enhanced engraftment / survival in an in vivo model of beta cell graft
rejection using humanized mice. Our strategy will induce localized tolerance to beta cell antigens
while simultaneously promoting sBC graft vascularization.

Public health relevance
PROJECT NARRATIVE The objective of this project is to induce localized immune tolerance to transplanted human beta cells derived from renewable stem cell sources as a treatment for type 1 diabetes. This project presents a significant step forward in the development of alternative, renewable, and off-the-shelf sources of insulin producing cells for current cell replacement therapy efforts. This project addresses the key technical challenge of systemic administration of immunosuppressive drugs to protect beta cell grafts through introduction of a highly localized immunomodulation and as such, represents the highest level of translational innovation.